Administrative Core

Yale Cancer Center Administration encompasses the Office of Research Affairs, YCC Finance and Clinical Trials Office, and Public Affairs and Communications, all of which work actively and collaboratively to support the essential components of the CCSG in carrying out the YCC mission. Administration is responsible for 1) providing efficient administration and management of essential CCSG functions; 2) facilitating and stimulating innovative cancer research, training, and outreach activities; and 3) monitoring and evaluating Center finances and administrative operations.
During the current project period, Administration made significant changes to improve workstreams. A core facilities management system was implemented to manage and track Shared Resource usage requests, equipment reservations, sample processing, billing, and invoicing. An improved database system to track membership and publication data was adopted and a system was developed to track and monitor return on investment for YCC’s internal grants program. All these changes allow for faster reporting of key Center metrics.
Administration plays a key role in planning and evaluation activities through the organization of advisory board meetings and was instrumental in the development of the Strategic Plan. Administration is responsible for monitoring and tracking progress towards the Strategic Plan and provides updates to leadership regularly.
An important goal of YCC is to promote high impact interdisciplinary cancer research. Administration contributes to this goal by fostering collaborations through the organization of Research Program meetings, retreats and administratively supporting the internal grants program. Over the current project period, cancer-relevant research funding increased to $94.9M and NCI funding increased to $26.5M (+9.5%). YCC’s grant portfolio includes three SPOREs, a UM1 and 10 U01 grants. The 305 YCC members published 2422 papers in the current period, 30% of these were in high impact journals and 82% represent inter-institutional collaborations. Administration’s efforts were key to supporting all these advances

An important goal of YCC is to promote high impact interdisciplinary cancer research. Administration contributes
to this goal by fostering collaborations through the organization of Research Program meetings, retreats and
administratively supporting the internal grants program. Over the current project period, cancer-relevant
research funding increased to $94.9M and NCI funding increased to $26.5M (+9.5%). YCC’s grant portfolio
includes three SPOREs, a UM1 and 10 U01 grants. The 305 YCC members published 2422 papers in the
current period, 30% of these were in high impact journals and 82% represent inter-institutional collaborations.
Administration’s efforts were key to supporting all these advances.
Future plans for Administration include re-evaluation of membership criteria, continue to work with Center
leadership to implement the Strategic Plan, support the newly launched Initiative to Address Disparities, and
foster high impact interdisciplinary cancer research by supporting the growing translational research
infrastructure.

Public health relevance
Yale Cancer Center Administration encompasses the Office of Research Affairs, YCC Finance and Clinical Trials Office, and Public Affairs and Communications, all of which work actively and collaboratively to support the essential components of the CCSG in carrying out the YCC mission. Administration is responsible for 1) providing efficient administration and management of essential CCSG functions; 2) facilitating and stimulating innovative cancer research, training, and outreach activities; and 3) monitoring and evaluating Center finances and administrative operations. During the current project period, Administration made significant changes to improve workstreams. A core facilities management system was implemented to manage and track Shared Resource usage requests, equipment reservations, sample processing, billing, and invoicing. An improved database system to track membership and publication data was adopted and a system was developed to track and monitor return on investment for YCC’s internal grants program. All these changes allow for faster reporting of key Center metrics. Administration plays a key role in planning and evaluation activities through the organization of advisory board meetings and was instrumental in the development of the Strategic Plan. Administration is responsible for monitoring and tracking progress towards the Strategic Plan and provides updates to leadership regularly. An important goal of YCC is to promote high impact interdisciplinary cancer research. Administration contributes to this goal by fostering collaborations through the organization of Research Program meetings, retreats and administratively supporting the internal grants program. Over the current project period, cancer-relevant research funding increased to $94.9M and NCI funding increased to $26.5M (+9.5%). YCC’s grant portfolio includes three SPOREs, a UM1 and 10 U01 grants. The 305 YCC members published 2422 papers in the current period, 30% of these were in high impact journals and 82% represent inter-institutional collaborations. Administration’s efforts were key to supporting all these advances